Molecular Analysis of Tweety Family Genes in Development and Tissue Homeostasis

Identified in animals, plants, and even simple eukaryotes, the tweety gene family is thought to encode gated
chloride channels important in the maintenance of cell volume. In vertebrates, the tweety gene family is highly
conserved and consists of three members, ttyh1, ttyh2, and ttyh3, all of which have strikingly different
expression patterns in the developing embryos. ttyh1 and ttyh3, display almost mutually exclusive expression
patterns in the developing nervous system, with ttyh1 expressed in the proliferative zone and ttyh3 present
almost exclusively in post-mitotic regions. ttyh2 is expressed in the eye and cranial nerves. Additionally, both
ttyh1 and ttyh3 are differentially expressed in RNA-Seq screens for genes that regulate the ability of embryos
to mount a profound compensatory or regenerative response following genetic and physical perturbations.
Despite the strong conservation in the vertebrate lineage, and being implicated in a wide range of human
diseases, particularly aggressive cancers, this family of genes has received relatively minimal attention. Given
the dynamic expression of ttyh1 and ttyh3 genes in embryogenesis, adult pathologies, and regenerative
responses, the overarching goal of this proposal is to elucidate their role in the developing embryo and in
developmental plasticity and homeostasis. Specific Aim #1 will focus on determining the roles of ttyh1 and
ttyh3 in normal embryogenesis using gain-of-function and loss of function experiments. Experiments will
employ Xenopus laevis, a classic model system for dissecting the role of developmental genes and an
emerging model for human disease, to perform standard, well-vetted approaches of ectopic expression using
mRNA injection and CRISPR to generate loss-of-function. Embryos will be assayed at key developmental
stages using whole mount in situ hybridization with a range of marker genes for the major developmental
pathways and cell types and single cell RNA-Seq to obtain global gene expression at a single cell level with the
goal of identifying the precise cell types and networks affected by the gain- and loss-of-function experiments.
Specific Aim #2 will focus on determining the role of ttyh1 and ttyh3 in early embryonic neural plasticity,
specifically their role in the recovery that occurs following physical (rotation of the anterior-posterior axis) or
genetic (overexpression of the Notch signaling pathway) perturbation. Genetic and physical perturbation will be
performed in a ttyh1 or ttyh3 mutant background generated via a CRISPR approach. The effect of ttyh1 and
ttyh3 knockouts on the recovery response will be assayed using the complementary approaches of whole
mount in situ hybridization and single cell RNA-Seq. Taken together, the proposed experiments will engage an
eager cadre of undergraduate students—both in course-based research and mentored lab research—in an
effort to elucidate the role of the tweety gene family and address fundamental, yet poorly studied, problems in
developmental biology that have broader implications for regenerative medicine.

Public health relevance
PROJECT NARRATIVE Highly conserved in all vertebrates, the tweety family of genes encode gated chloride channels that regulate numerous physiological processes and are implicated in a wide array of human diseases, particularly aggressive cancers. Despite their developmental and clinical importance, the role of these genes is poorly understood in development and tissue homeostasis. The goal of this proposal is to elucidate the role of the tweety genes ttyh1 and ttyh3 in normal development and in response to perturbations with the goal of providing foundational knowledge for developing future disease biomarkers and possible therapeutics.